Administrative Core

PROJECT SUMMARY
The Administrative Core will provide operational oversight for the Center for Translational Pediatric Research
(CTPR) at the Arkansas Children’s Research Institute (ACRI) during COBRE Phase II. The Center Director, Dr.
Alan Tackett, will lead the Administrative Core both in the scientific and mentoring missions. Dr. Tackett is a
nationally recognized leader in the scientific focus of the CTPR and has extensive administrative and mentoring
experience. Dr. Robert Eoff, Center Deputy Director, will provide additional support in the operational oversight
of the center. The long-term goal of the Administrative Core is to strengthen biomedical research infrastructure
by providing administrative oversight and a Faculty Development Plan that will enhance the ability of
investigators to compete for complementary NIH individual research grants or other equivalent extramural
support, and ensure the longevity of the CTPR as a thematic, multi-disciplinary, state-of-the-art research center.
The shorter-term goal during Phase II is to build upon the success of Phase I and strengthen the foundation for
achieving the long-term goal by implementing administrative oversight of the center, executing the Faculty
Development Plan for the CTPR Project Leaders, establishing productive and efficient Core Facilities,
overseeing a Pilot Project Program to seed the growth of new faculty in the center, and providing critical
evaluation of progress. To achieve the long-term and short-term Phase II goals of the CTPR, the center
leadership will pursue the following Specific Aims in the Administrative Core: (1) Provide for the long-term
success of the CTPR by establishing and supporting a thematic, multi-disciplinary, state-of-the-art research
center with cutting-edge research, research training and career development opportunities, (2) Execute a
comprehensive Faculty Development Plan for mentoring Research Project Leaders for their transition to and
attainment of independent investigator status, (3) Administer a Pilot Project Program to seed the growth of faculty
in the CTPR, and (4) Provide comprehensive evaluation of the CTPR using quantitative milestones and goals
as metrics.